Determining intracellular signaling events that control CAR T cell death in vivo.

PROJECT SUMMARY/ABSTRACT The goal of this F31 application is to investigate intracellular signaling events that promote death of tumor-specific T cells in vivo. To achieve appropriate immune homeostasis, populations of effector T cells and regulatory T cells must be tightly controlled. Cancer is one disease state where regulatory T cells can suppress effector T cells and prevent elimination of tumors. To overcome immune suppression and tolerance that occurs during cancer, adoptive T cell therapies have been introduced clinically, including adoptive transfer of CAR (chimeric antigen receptor) T cells. CAR T cells contain TCRs with tumor antigen specificity, a signaling component of the TCR (CD3 zeta chain) as well as one or more co-stimulatory domains (such as CD28). CAR T cells are efficiently activated and have been very effective for the treatment of some cancers, especially hematologic cancers. One problem, however, is that CAR T cells often do not persist in vivo, especially for solid tumors, and have been shown to undergo activation induced cell death (AICD). Currently, knowledge of the mechanisms of CAR T cell death and strategies to promote CAR T cell survival are limited. We discovered a novel form of AICD that occurs when effector T cells are stimulated on anti-CD3 and anti-CD28 coated plates. This process is dependent on p53 and is termed PICA (p53-induced CD28 dependent T cell apoptosis). We found that that effector T cells die during PICA, but that Foxp3+ regulatory T cells are resistant to PICA through TGF-β signaling. Our data also show that effector CAR T cells stimulated with large numbers of antigen-expressing cells (>1:20) undergo cell death. The CAR T cells that survive this high dose antigen stimulation are Foxp3+. We therefore hypothesize that CAR T cells undergo PICA when stimulated with high dose antigen. Elucidating this mechanism of CAR T cell death can help us better design CAR T cells that persist and kill more efficiently in vivo. While investigating PICA in effector T cells, we discovered that the protein RasGRP1, a Ras activator, is highly elevated in effector T cells after repeated stimulation. Tregs maintain low levels of RasGRP1, and this is dependent on TGF-β signaling. We currently do not know the function and phenotype of CAR T cells that survive high dose antigen stimulation from solid tumors in vivo, and if RasGRP1 promotes CAR T cell death in vitro and in vivo. Aim 1 will determine if CAR T cells that survive stimulation by solid tumors in vivo are Foxp3+ and functionally suppressive, due to TGF-β signaling. Aim 2 will determine if RasGRP1 promotes death in CAR T cells, and if engineering a CAR with dominant negative RasGRP1 can rescue CAR T cell death and promote tumor killing in vivo. Overall, we expect this study to illuminate mechanisms of CAR T cell death, which can aid in promoting CAR T cell survival in solid tumors. Additionally, this study will test the use of a novel CAR construct, which we predict will enhance CAR T cell survival and could inform future design of CAR T cells that are used clinically.

Public health relevance
Project Narrative Adoptive T cell therapy with tumor-specific engineered T cells has shown great promise in the elimination of several kinds of cancers, but elimination of solid tumors remains a challenge. This is partly due to death of these tumor-specific T cells in vivo. The goal of this proposal is to investigate intracellular signaling events that promote tumor-specific T cell death, with the hopes of identifying ways to engineer these T cells to survive better and promote more efficient killing of solid tumors in vivo.